Genome engineering of stem cells for kidney regeneration.

Acute kidney injury is a diagnosis associated with significant morbidity and mortality in the
Veteran population. Therefore, we propose to develop a regenerative treatment for acute kidney
injury based on progenitor cell exosomes. Recent studies suggest that the therapeutic effects of
stem or progenitor cells are at least partially mediated through exosomes, a subset of
extracellular vesicle. Exosomes are advantageous as they can be lyophilized for storage, are
generally non-immunogenic, and do not require culture of cells just prior to therapeutic
administration. The stem or progenitor cell type that will be utilized for this study is the induced
nephron progenitor cell. Nephron progenitor cells form most of the differentiated cell types of the
adult nephron, but are exhausted just prior to birth in humans. Induced nephron progenitors are
derived from adult human cells in tissue culture through transcription factor reprogramming with
inducible piggyBac transposons. The reprogramming factors are SNAI2, EYA1, and SIX1. We
have isolated and characterized exosomes from induced nephron progenitor cells and find them
to be abundant. Our preliminary data demonstrate that induced nephron progenitor exosomes
have regenerative and protective properties in the HK-2 tubule cell line, human kidney
organoids, and mouse models of acute kidney injury. However, further development is
necessary to bring this potential therapeutic forward from bench to bedside. In Aim 1, we
hypothesize that the exosomes will reduce markers of kidney injury in ischemia reperfusion and
rhabdomyolysis mouse models of acute kidney injury. We will administer the induced nephron
progenitor exosomes before, concurrent with, immediately after, and one day following injury
and evaluate histology as well as markers of kidney function to determine the therapeutic effects
on acute kidney injury. In Aim 2, we hypothesize that the induced nephron progenitor cell-
derived exosomes protect human tubule cells from apoptosis induced by nephrotoxicants
through specific protein and/or RNA species that can be modulated through genome
engineering strategies to further enhance nephron progenitor extracellular vesicle efficacy.
These studies will accelerate the translation of next-generation extracellular vesicle therapies
based on advanced cell and genome engineering techniques for treatment of acute kidney
injury.

Public health relevance
Acute kidney injury is common, affecting 22% of Veterans admitted to VA intensive care units. As such, acute kidney injury is a major cause of morbidity and mortality in the Veteran population, and Veterans who survive are at risk of developing chronic kidney disease or end-stage renal disease. One in seven people in the United States has chronic kidney disease. Patients with end-stage renal disease require dialysis or kidney transplantation for survival. Kidney regeneration is poor following acute kidney injury and there are no treatments available at this time to directly encourage regeneration. New treatments that target regeneration of the kidney are needed. The human kidney is comprised of a limited set of nephrons that are present at birth. These nephrons are lost over time and can never be regained, so renal injuries can be lifelong. We seek to explore the use of reprogrammed progenitor cells and their extracellular vesicles for kidney regeneration.